BCCMA: Predicting TBI Pathology with Visual and Blood-based Biomarkers

The purpose of this collaborative project is to identify robust biomarkers that predict chronic neuronal
dysfunction following traumatic brain injury (TBI). Evaluating TBI-induced pathology and dysfunction in the
brain can be challenging. We hypothesize that the retina can serve as a surrogate to monitor
the rate of neurodegeneration occurring in the brain following injury. Furthermore, we hypothesize that
blood-based biomarkers correlate with TBI-mediated neurodegeneration in the retina and brain. The
first phase of this project is the discovery phase with the objective of identifying biomarkers that are predictive
of chronic neuronal damage. Three distinct proposals will examine both blast-mediated and impact TBI
using overlapping assessments of retinal function and structure. Each proposal will also utilize unique
outcomes including proteomic analysis of the blood and serum, cognitive function, brain imaging modalities,
and histology in both animal models and Veterans. A fourth project will use data from the first three projects to
apply tissue modeling and informatic approaches to fully characterize TBI injury in the retina and brain. The
second phase will validate the candidate biomarkers identified by each site by testing animals/tissue, and
human biofluid samples in the other laboratories. This phase will determine the robustness of each biomarker
across studies. In the third phase, we will test the most promising biomarkers in mice exposed to live blast
explosions, providing translational value to the biomarkers.
Project 4 (this project) will manage big data and analytics (statistics, computational modeling, and
machine learning/AI) for the Linked Merit. The rich TBI measures produced by Project 1-3 will create a specific
type data management challenge: big data variety1. We will manage this data variety across projects using
data science and advanced analytics to assess multiple injury severities and types in a unified pipeline. By
pooling and aligning diverse data at a granular level, it becomes possible to make TBI biomarker data
Findable, Accessible, Interoperable and Reusable (FAIR)2, making complex data manageable, improving
biomarker discovery, enhancing quality control (QC) and reproducibility, and enabling advanced analytics
to drive translational therapeutic development. The present Linked Merit leverages our prior efforts to build
infrastructure enabling FAIR data sharing, data citation and query, and multidimensional analytics;
repurposing them to promote biomarker discovery, assess reproducibility, and cross-validate findings. We
will establish a TBI Open Data Commons pipeline for biomarkers (Aim 1). We will ingest and cross-curate
animal data from Project 1 [Harper], Project 2 [Feola], Project 3 [Wang] and Co-I Thao (Vicky) Nguyen will
use sensor data from these studies to develop biofidelic computational models of blunt TBI, shock-tube
blast, and open field blast experiments to determine and compare the stresses and deformation of the
tissues of the eye (retina, optic nerve head) and optic tract at the base of the rat/mouse brain (Aim 2). We will
then work closely with Project PIs and clinician-scientist Co-I Fanny Elahi to perform clinicopathological
analysis of retinal and biofluid biomarkers as reproducible and cross-species translational predictors of
functional outcomes in TBI (Aim 3), harnessing a combination of traditional statistics and machine learning/
machine intelligence tools. This approach will ensure rigor and reproducibility of validated retinal and blood-
based biomarker associations for diverse TBI types. Through this work the Linked merit will take tangible
steps toward realizing the potential of biomarkers to predict neurodegeneration and drive precision therapeutic
targeting.

Public health relevance
Traumatic brain injury (TBI) is a condition with higher prevalence in the veteran population than civilians and is associated with multi-dimensional impairments in function impacting neurocognition, psychological well-being, personality, motor function, and activities of daily living. These impairments have diverse biological causes, producing a challenge for both scientific reproducibly of therapeutic discoveries as well as bench-to-bedside translation of discoveries into veteran healthcare. Project 4 of the proposed linked merit will take a data-science approach to TBI biomarker discovery, integrating data on retinal function and structure, blood biomarkers, biomechanical modeling and outcomes in multiple rodent models of TBI (blast, contusion, percussion, weight drop injuries) produced by Projects 1-3. Harnessing data science and machine intelligence tools we will help identify biomarker signatures predicting TBI impairment and help validate biomarker measures for translation and precision medicine.